DNA Methylation Dynamics of Mammalian Development

PROJECT SUMMARY
The progression from a pluripotent state into the myriad cell types that arise during mammalian development
involves a host of epigenetic properties that dictate gene expression patterns and enforce the commitment of a
cell to a specific lineage. The advent of single-cell genomics has enabled the study of cell lineage dynamics at
unprecedented resolution; however, such studies have been largely limited to RNA transcription. The dynamic
modulation of the epigenome that governs these processes involves multiple layers of regulation, including a
major role by DNA methylation – a canonically repressive property that can act as a gatekeeper of genomic
permissiveness. Aberrant DNA methylation is also associated with numerous developmental disorders and
diseases; however, it is also one of the least studied properties, particularly at the single-cell level, primarily due
to technological limitations. We have recently addressed this shortcoming with the development of a high-
throughput single-cell DNA methylation assay capable of producing 100’s of thousands of cell profiles in a single
experiment, paving the way for studies of this property with a power comparable to that of transcription. Here we
propose the production of at atlas of DNA methylation during mammalian embryonic development in the mouse
at 24-hour increments from embryonic day 8.5 to 17.5 in order to produce a granular map of DNA methylation
dynamics during key stages of lineage priming and commitment. We will further assess the intestinal epithelium
using novel multiomic technologies in order to gain mechanistic insight into how layers of epigenetic control drive
and enforce one another. These data will enable the assessment of standing hypotheses regarding the role of
DNA methylation in genomic permissiveness and cell fate decisions. Finally, the datasets, which will represent
a powerful resource for developmental biology and epigenomic studies, will be made openly available through
interactive portals to enable broad access by the greater research community.

Public health relevance
PROJECT NARRATIVE DNA methylation is one of the oldest known epigenetic modifications to the genome, playing an important role in the gene regulatory landscape by typically acting in a repressive context, with aberrant DNA methylation observed in various diseases and developmental disorders. Despite its importance, this property has not been assessed during the dynamics of mammalian development at high-resolution. We have developed new tools that will enable us to address key hypotheses regarding the mechanistic role of DNA methylation in conjunction with other epigenetic properties that will we apply to the developing mouse embryo with a further focus on intestinal epithelial cell lineages.